The Impact of the COVID19 Pandemic on the Hispanic/Latinx Birth Outcome Advantage

Project Summary
This project focuses on whether the COVID-19 pandemic has put the well-established Hispanic
infant health advantage in peril. The U.S. Hispanic population has been one of the hardest hit by
the COVID-19 pandemic with some of the highest rates of hospitalization, death, and illness,
due in large part to overrepresentation in frontline occupations. The adult mortality impact on the
Hispanic American population has been stark—Hispanic life expectancy experienced the largest
decline across all racial/ethnic groups, with the exception of non-Hispanic AIAN population. The
impact on infant health, however, is not yet known. We leverage U.S. Natality data (2015-2022)
to first determine whether Hispanic perinatal outcomes have been impacted by the COVID-19
pandemic, for the overall population and disaggregating by three critical sources of
heterogeneity in the Hispanic population—nativity, region-of-origin, and maternal education
level. Second, given pronounced temporal and geographic variation in the pandemic’s
progression, we determine whether impacts vary at the county-level and by county-level disease
burden. Third, we assess whether either county poverty level and/or Hispanic concentration
moderates the identified impacts. Determining if, for whom, and in what context, the Hispanic
birth advantage has been impacted by the pandemic is critical for determining where to focus
resources, not just at birth, but also at other stages of child development. Establishing these
patterns is a fundamental piece of a full accounting of the extent of the pandemic’s toll on our
country, particularly how it altered the health of such hard-hit U.S. sub-populations as Hispanic
Americans.

Public health relevance
Project Narrative The stakes for determining whether the surprisingly resilient infant health advantage observed among U.S. Hispanics has been imperiled by the COVID-19 pandemic are high. Healthy birth outcomes set the stage for the health and well-being across the life course, with poor perinatal outcomes producing enduring effects in later life. If the Hispanic infant health advantage has indeed been threatened, then there are likely long- term consequences for inequality that urgently need to be documented in order to determine where to focus resources, not just at birth, but also at other stages of child development.